Tau accumulation in the pedunculopontine tegmentum as an early node in Progressive Supranuclear Palsy pathogenesis

Summary Progressive Supranuclear Palsy (PSP) is a debilitating disease with aggregates of tau protein in multiple brain areas and severe mental and motor deficits. PSP is often misdiagnosed as Parkinson's Disease (rate of 50%) and there are no drugs that help PSP sufferers. Those with PSP have a life expectancy of only 6-8 years, suggestive that the neurodegeneration is already far advanced when symptomology becomes evident. Therefore, there is a need to i) increase the accuracy of diagnosis, ii) find biomarkers or behavioral deficits that predate the symptoms, and iii) find therapeutics. To facilitate these goals, we need to understand 1) from where within the brain does the disease originate, 2) which neural pathways when degenerated produce which symptoms, and 3) the topographical progression of pathogenesis. Based on strong preliminary data, we propose that the accumulation of tau protein in cholinergic pedunculopontine tegmentum (PPT) neurons in the hindbrain will produce tau aggregates in brain regions impacted in PSP, progress from a disease-free state to a PSP-like end stage, and produce PSP-like behavioral deficits (e.g. dysexecutive frontal syndrome and motor deficits). To produce PSP-like pathology in rats we use a genetically engineered virus to selectively over-express the isoform of the tau protein that predominates in PSP (1N4R) in cholinergic PPT neurons. At 5 months post- infection, the model is consistent with PSP: i) a loss of cholinergic neurons, ii) loss of substantia nigra dopaminergic neurons, iii) increased number of hyperphosphorylated tau-positive neurons, iv) acoustic startle reflex deficit, and v) motor deficits. Animals with tau protein over-expression will be compared to those that have the over-expression of a benign protein at 5 month intervals until old age. We will complete extensive postmortem histochemical analysis, Magnetic Resonance Imaging (MRI), REM sleep recordings, and behavioral testing (e.g. cognitive & motor) to establish whether the pathology progresses to a condition consistent with late-stage PSP. Once it is established that accumulation of tau in the cholinergic PPT neurons is sufficient to produce late stage PSP-like pathology and behavior deficits, future work would include: 1) identifying strategies that ameliorate symptomology and disease progression, 2) the discovery of early markers of disease onset, and 3) molecular mechanistic studies (e.g. knockdown of specific targets).

Public health relevance
Narrative Progressive Supranuclear Palsy (PSP) is a devastating neurodegenerative disease, which shares attributes with Alzheimer's Disease; tau protein aggregates, cognitive and motor deficits. Our goal is to identify neurons that are perturbed early in the disease process and that contribute to key aspects of the behavioral deficits and underlying pathology. This knowledge will allow for improved diagnosis and the initiation of pharmacotherapeutic discovery programs.